PCT-KUH: Pittsburgh Center for Training in Kidney, Urology and Hematology

The mission of the Pittsburgh Center for Training in Kidney, Urology and Hematology (PCT-KUH) is to develop
the next generation of KUH investigators. This training program will prepare predoctoral students, physicians
and PhDs for biomedical research careers by providing a concentrated, in-depth research experience. The
program is designed to foster a rigorous approach to scientific inquiry in basic science or clinical investigation.
Three areas of research are emphasized: kidney, urology and benign hematology. Trainees will develop a
research project under the close supervision of a faculty trainer and will be closely monitored by an
independent advisory or dissertation committee, as well as by the research training executive committee. An
intensively structured research experience will be supplemented by didactic lectures, research seminars,
journal clubs, formal course work, attendance at scientific meetings, and structured professional development
and networking cores. Professional development will encompass opportunities to develop skills in grant writing,
scientific communication and team science, facilitate career development and resilience, and provide mentor
training. The network core will build a robust community of learners in the KUH space around already existing
training programs in the Pittsburgh region and the trainees funded by PCT-KUH, and enhance community
outreach to attract diverse individuals to careers in biomedical science. Predoctoral graduates of this
comprehensive training experience will be equipped to compete for individual training support. Postdoctoral
graduates of this program will be prepared to compete for independent funding and entry-level faculty positions
in academic medicine and industry.

Public health relevance
Our U2C/TL1 program fosters a rigorous approach to scientific inquiry in the areas of basic, translational and clinical investigation, while providing programs for professional development and networking opportunities. Our trainees publish novel science, attain fellowship and career development awards, and transition to independent research careers. Our goal is to train a new generation of scientists to be future leaders in the fields of nephrology, urology and hematology.